Optimizing Cognitive Remediation in VA Mental Health Rehabilitation Settings

Over one hundred thousand Veterans annually utilize mental health residential rehabilitation programs
(RRTPs) and psychosocial rehabilitation and recovery centers (PRRCs). Through support and comprehensive
programming, these mental health rehabilitation milieus help Veterans with mental illness overcome barriers to
community reintegration. Despite the success of these milieus, cognitive impairment is commonly observed in
Veterans with mental illness, reduces gains from programming, and limits successful recovery. Cognitive
impairment is a common transdiagnostic illness dimension conferred both directly and indirectly by mental
illnesses. Cognitive rehabilitation through remediation strategies can potentially attenuate cognitive impairment
for these Veterans and improve outcomes, but there are two inter-related problems that limit the effectiveness
of such interventions. First, we are not able to identify which Veterans will benefit from mental health
rehabilitation programming at program entry. Second, we are not able to predict which Veterans are going to
benefit from any specific cognitive remediation intervention.
This CDA-2 application seeks to test whether an electroencephalographic (EEG) biomarker, mismatch
negativity (MMN), can be used to predict Veteran recovery in mental health rehabilitation treatment settings,
and identify Veterans who will respond to cognitive remediation interventions. MMN is an event-related
potential which is considered to be a biomarker of information processing, linked to cognition in healthy
subjects and cognitive impairment in a variety of neuropsychiatric illnesses. MMN also mediates psychosocial
and functional outcomes in individuals without any psychiatric comorbidities and individuals with mental illness.
Recent work also suggests that MMN can identify individuals who will experience gains from a full course of
cognitive remediation when measured over the first hour of cognitive remediation. These biomarker
relationships (cognition, cognitive remediation sensitivity, functioning) have not yet been definitively established
in a heterogenous Veteran population receiving care in real-world settings like RRTPs and PRRCs.
Veterans with mental illness will be recruited from the VA San Diego Healthcare system RRTP and PRRC at
program entry. Baseline measures of functioning, psychosocial disability, cognition and treatment engagement
will be collected. Following these assessments, Veterans will undergo testing to collect MMN data, and then
will be challenged with a one-hour cognitive remediation exercise, which is a typical component of full multi-
hour cognitive remediation programs. Veterans will be followed with monthly assessments of psychosocial
disability and treatment engagement. At the end of study, functioning will also be re-assessed.
If successful, results from the studies proposed will create an objective, precision-medicine platform which
could fundamentally change how RRTP and PRRC approach rehabilitative programming for Veterans with
mental illness. In carrying out the studies proposed, the PI will gain critical training in advanced EEG biomarker
analyses, computational/statistical methodology and clinical trial design and implementation which will expand
his scientific skill set and lead to scientific independence. This CDA-2 will allow the PI to work towards his
career goal of using EEG biomarkers to personalize cognitive rehabilitation interventions for Veterans with
mental illness.

Public health relevance
Veterans with mental illness face challenges with community reintegration, including achieving vocational success, attaining their educational goals and going back to school, and maintaining a high quality of life. VA mental health Residential Rehabilitation Treatment Programs and Psychosocial Rehabilitation and Recovery Centers are designed to help Veterans overcome these barriers, but cognitive impairment often seen in Veterans with mental illness limits gains from these settings. Cognitive remediation interventions can be helpful, but they are either “one-size fits all,” and thus may not be useful for all Veterans with mental illness, or are too narrow in scope, focusing on specific mental illnesses, limiting generalizability. This project will test whether an objective biomarker can better match the “right” Veteran to the “right” cognitive remediation treatment regardless of their specific mental health diagnosis. Information gained from this study will help establish a precision-medicine approach towards cognitive rehabilitation for Veterans with mental illness.